Cardiovascular risk and circadian misalignment in short sleepers- role of extended eating period.

PROJECT SUMMARY
In spite of increased public awareness, voluntary sleep curtailment remains prevalent and pervasive in our
society. Currently, more than one-third of the US adult population report sleeping 6h or less most nights. This is
problematic as short sleep duration contributes to high cardiovascular (CV) risk and consequent increased CV
disease and mortality. Increasing sleep duration mitigates the metabolic impairment, but alternate strategies to
reduce cardiometabolic risk in habitual short sleepers are lacking. This is especially important when increasing
sleep duration is unsuccessful. Unfortunately, the mechanisms underlying metabolic detriments in short sleepers
are not completely understood. This hinders the development of alternate strategies for CV prevention. In recent
years, the importance of circadian system in maintaining a healthy metabolism is recognized. The circadian
system coordinates 24h periodicity in essential physiological and behavioural function and thus represents a
fundamental component of homeostasis. Conversely, flattening and/or misalignment of the endogenous
circadian rhythms (melatonin secretion) with fasting/feeding behaviour can cause metabolic dysfunction such as
high blood pressure (BP) and insulin resistance (IR). In short sleepers, nighttime exposure to artificial light and
extended eating duration may decrease and delay melatonin secretion. However, no study has examined the
circadian and metabolic effects of eating duration in this population. We hypothesize that extended eating
duration contributes to high BP and IR in habitual short sleepers via altered melatonin secretion.
Therefore, time restricted eating (TRE) will lower BP and IR by increasing and aligning melatonin
secretion to fasting/feeding. Indeed, several TRE clinical trials have shown CV risk reduction in participants
with obesity, pre-diabetes, and metabolic syndrome. Interestingly, a recent study suggested that metabolic
consequences of circadian misalignment likely results from misalignment of fasting/feeding with endogenous
circadian rhythm. Support for our hypothesis comes from these prior studies and preliminary data showing that
TRE reduces BP and IR in short sleepers. We will test our hypothesis by conducting an randomized, parallel
arm study in participants with confirmed habitual short sleep (≤6.5h/night) and eating window of >14h/day in out-
patient settings. Participants (n=100, age 18-45y; BMI 25-35kg/m2) will undergo a 4-week intervention during
which they will be randomly assigned to habitual eating duration (>14h/day, control) or shortened eating duration
(TRE, 8h/day). Ambulatory 24h hour BP (Aim 1), glucose metabolism (mixed-meal tolerance test, Aim 2), and
melatonin diurnal rhythm (Aim 3) will be assessed at baseline, mid- and end- intervention to gain temporal
insights. To ensure compliance with assigned eating duration and study protocol, we will continuously monitor
glucose, physical activity, sleep duration, and light exposure. Our study provides mechanistic insights into
circadian dysregulation in short sleepers and corresponding beneficial effects of TRE. The clinical translational
impact of the study is in the identification of TRE as an alternate strategy to offset CV risk in short sleepers.

Public health relevance
PROJECT NARRATIVE Short sleep duration confers high cardiovascular and metabolic risk, but lifestyle factors and molecular mechanisms that contribute to increased blood pressure and poor glucose control during short sleep are not completely understood. Habitual short sleepers are constantly eating, the proposed studies will evaluate if this behavior contributes to heightened cardiovascular and metabolic risk, and will examine if this may be related to eating during night. Our study will identify restricted eating duration (8 hours/day) as a potential way to improve cardiovascular and metabolic health in habitual short sleepers.